Methods for multi-ancestry and multi-trait fine-mapping and genetic risk prediction

Project Summary: Two fundamental goals in genetic epidemiology are the identification of genetic variants
that cause disease (fine-mapping) and the development of polygenic risk scores (PRS) that predict individual-
level disease risk using genetic information. As genetic datasets expand, these goals become increasingly
realistic. However, most genetic datasets overrepresent European populations, limiting the generalizability of
scientific findings, the discovery of causal variants, and the accuracy of PRS in non-European populations. If
unaddressed, differences in PRS accuracy will widen ancestry-based health disparities. Most methods in
genetic epidemiology consider one ancestry and disease at a time. This research proposes methods for causal
variant identification and genetic risk prediction that share information across ancestries and diseases.
The first aim is to develop a method for fine-mapping using data from multiple ancestry groups. Causal
variant identification provides insight into disease etiology and helps researchers identify drug targets. The sum
of single effects (SuSiE) model is a powerful approach for fine-mapping in a single population. Incorporating
data from multiple populations can greatly improve fine-mapping due to ancestry-based differences in patterns
of correlation between variants and the presence of variants with causal effects in some, but not all ancestries.
In this aim, MultiSuSiE, a multi-population fine-mapping method motivated by SuSiE will be developed and
applied. SuSiE provides substantial benefits in terms of speed, power, and interpretability compared to other
fine-mapping methods. MultiSuSiE will bring the state-of-the-art in fine-mapping to the multi-ancestry context.
The second aim is to develop and apply ssCTPR, a summary statistic based PRS method that
leverages shared information across diseases. PRS show great promise for informing medical treatment
decisions and disease screening interventions. A recent method, cross-trait penalized regression (CTPR),
boosts prediction accuracy by leveraging shared genetic bases across diseases but requires difficult-to-obtain
individual-level data. In this aim, ssCTPR, a multi-trait summary statistic-based method motivated by CTPR will
be developed and applied. ssCTPR is innovative in its statistical approach: ssCTPR will jointly model variants
and diseases, use penalized regression, and share information across traits using a Laplacian quadratic
penalty that is effective in the multi-disease setting, but has not been investigated using summary statistics.
The third aim is to develop a method that uses the methodological advances of aims 1 and 2 to improve
PRS prediction in non-European populations. PRS prediction accuracy in non-European populations is much
lower than in European populations. As PRS enter the clinic, populations with inequitable health outcomes will
fail to benefit from the latest in precision medicine innovation. In this aim, MultiPolyPred, a method that models
individual risk using multi-ancestry fine-mapping and a multi-disease PRS will be developed and applied. Our
method will be the only non-European PRS method to leverage multi-ancestry fine-mapping.

Public health relevance
Project Narrative Two fundamental goals of genetic epidemiology, the estimation of individual-level disease risk and the identification of mutations that cause disease, promise to help inform personalized medical interventions, identify drug targets, and elucidate disease biology. However, existing genetic datasets overrepresent European ancestry individuals, limiting the identification of causal mutations and accuracy of disease risk prediction in non-Europeans populations, exacerbating ancestry-based health disparities. Most methods in genetic epidemiology consider data for one ancestry and disease at a time, whereas we will develop methods that share information across ancestries and diseases to further these fundamental goals in an equitable and powerful way.